Effects of early-life neglect and cocaine use on PTSD-like behaviors

PROJECT SUMMARY
The high degree of comorbidity between substance use disorder (SUD) and post-traumatic stress disorder
(PTSD) in the US population suggests that similar underlying mechanisms contribute to both disorders such that
having one disorder may predispose one to develop the other. A study of a mostly African-American urban civilian
population found that their levels of cocaine use highly correlated with levels of childhood abuse and PTSD
symptoms. This suggests that childhood abuse, cocaine addiction, and PTSD interact in minority populations
and likely contribute to worse outcomes and health disparities. The vast majority of animal models examine
cocaine use and PTSD separately. However, to be able to design better treatment plans for real-life clinical
scenarios, we need to understand how these two disorders interact. In this project, we propose to combine
animal models of child abuse and neglect with models of cocaine abuse and PTSD to examine to what degree
one condition affects the other and to examine whether exposure to cocaine at different developmental stages
increases the severity of PTSD-like phenotypes. Our central hypothesis is that developmental stress and cocaine
abuse interact to increase the susceptibility to and worsen the severity of PTSD-like symptoms after trauma
exposure in adulthood by altering overlapping neuronal circuits. Substance abuse often begins during
adolescence, during which time the prefrontal circuits and hippocampal modulation of behavior is still being
refined. Therefore, early life stress and adolescent cocaine exposure could alter hippocampal modulation of
conditioned fear, potentially leading to increased susceptibility to more severe PTSD-like behaviors in adulthood.
To begin to address these issues, in Aim 1, we will first evaluate whether early life neglect and adolescent cocaine
use interact to increase susceptibility to and generalization of conditioned fear or impair fear extinction in a rat
model. In Aim 2, we will evaluate whether fibroblast growth factor-2 mediates the effects of early life neglect
and adolescent cocaine use on fear generalization and extinction. In Aim 3, we will evaluate how early life neglect
and adolescent cocaine use interact to alter the excitability of the ventral hippocampus-to-infralimbic cortex
portion of the fear circuit. Thus, we will examine the effects of developmental stress and cocaine use on PTSD-
related behaviors from a behavioral, circuit, cellular, and molecular level. The Research Resources Core will
provide essential support for this project, since the completion of this project's aims will require behavioral and
molecular analysis.

Public health relevance
PROJECT NARRATIVE Childhood neglect, cocaine addiction, and PTSD interact and likely contribute to worse outcomes and health disparities. Our proposed aims will provide a deeper understanding of the cellular, circuit, and behavioral effects of early life neglect and adolescent cocaine use in an animal model of PTSD. A better understanding of how these factors interact may lead to better treatments for comorbid cocaine addiction and PTSD.